Modeling, measurement and prediction of cardiac magneto-stimulation thresholds

Project Summary/Abstract
In MRI, cardiac stimulation (CS) is the direct stimulation of the heart by rapid switching of the gradient
coils, a phenomenon referred to as magneto-stimulation. The Federal Drug Administration (FDA)
imposes limits on the speed and amplitude of gradient switching in MRI, however there is an almost
complete lack of data on magneto-stimulation, which has resulted in a necessarily restrictive safety
limit. Instead, the IEC 60601-2-33 limit for CS in MRI, which is the limit that the FDA relies on, is
based on simplified electric field calculations in uniform cylinders that mimic the human torso, and
open-chest CS experiments performed in animals using electrodes. Because of the known limitations
of this methodology, the IEC built in large safety factors in their choice of the CS limit, thus resulting in
a conservative safety recommendation. For example, for the four Siemens Connectome scanners in
use, the CS safety limit is more restrictive than the peripheral nerve stimulation limit at long rise times,
which is unlikely since conducting cells in the myocardium are harder to stimulate than large
peripheral nerves and the heart is deep inside the body, and therefore more shielded from electric
fields than shallow nerves. As the IEC MRI cardiac stimulation safety limit becomes more and more
restrictive for improving gradient systems, it is essential to study the magneto-stimulation
phenomenon in a more detailed manner using direct animal measurements and state-of-the-art
simulation methods.
To our knowledge, only two groups have published direct measurements of cardiac magneto-
stimulation performed, in dogs, in the early 1990s. We propose a multidisciplinary bioengineering
research project that aims to measure, for the first time, cardiac magneto-stimulation
thresholds in pigs, a widely used animal model for the human cardiovascular system. In
addition, we develop a detailed simulation pipeline of cardiac magneto-stimulation using
state-of-the-art modeling techniques in order to shed light on the mechanisms of action of CS
in MRI and estimate stimulation thresholds in humans for a variety of coils and gradient
waveforms. We will work closely with the MT40 sub-committee of the IEC throughout the duration of
the project in order to ensure that our work maximally informs the setting of the IEC limit in the next
update of the IEC 60601-2-33 standard.

Public health relevance
Project Narrative The Federal Drug Administration sets strict limits on how MRIs can operate to avoid any possible stimulation of the heart. However, the lack of data on how temporally changing magnetic fields interact with the heart hampers our ability to know the detailed limits that should be applied and has led to a necessarily conservative approach which restricts the operation of the latest generation of MRI gradient systems. To address this, we perform the first measurement of cardiac magneto-stimulation on pigs, a widely used animal model for the human cardiovascular system, and develop a detailed modeling pipeline of the cardiac magneto-stimulation phenomenon.